Registering Cancer Recurrences in the Georgia Cancer Registry

There are 15 million US cancer survivors, most diagnosed with early-stage disease, so at risk for a
cancer recurrence. There is no population-based information about the risk of cancer recurrence. For decades,
mortality has been the only outcome available to monitor progress in cancer care. As cancer care has
improved, however, the correspondence between recurrence and mortality has diminished. A recent
commentary in the Journal of the National Cancer Institute emphasized that the lack of surveillance data on
recurrence is a barrier to comparative effectiveness research in the realm of cancer care and to research on
cancer quality-of-care. In the clinical setting, the lack of even basic recurrence risk data by cancer type and
stage is a barrier to informed patient-physician decision-making and risk stratification. A high-quality registry of
cancer recurrences would fill these gaps, open new avenues for cancer research, and enable improvements in
clinical care tied directly to the most salient and immediate outcome for all early-stage cancer patients.
Georgia provides an ideal setting for the first-ever registry of cancer recurrences. The population of
about 10 million is diverse with respect to all major demographic characteristics. The large population ensures
that adequate data on recurrences will accumulate rapidly. The diverse population assures that heterogeneity
of recurrence risk by demographic characteristics will be adequately characterized. The Georgia Cancer
Registry has been a long-term member of the National Cancer Institute’s Surveillance Epidemiology and End
Results program, the National Program for Cancer Registries established by the Centers for Disease Control
and Prevention, and the North American Association of Central Cancer Registries. Thus, Georgia has the right
population and the Georgia Cancer Registry has the right infrastructure to accomplish the following two aims:
Aim #1: Use six data streams to signal potential recurrences occuring among Georgia cancer survivors
diagnosed with one of four cancer types (breast, prostate, colorectal, or lymphoma), review medical records to
validate true recurrences, and implement constant learning processes to improve accuracy, efficiency, and
sustainability of the registration process.
Aim #2: For these four cancer types, which represent 43% of incident cases and 58% of prevalent survivors in
the US, generate the first-ever descriptive data on the risks and rates of recurrence over ten years of follow-up
and evaluate how these vary by demographic characteristics.
By achieving these aims, we will fill an important gap in the knowledge base regarding cancer outcomes and
provide a foundation for innovative research on patterns and predictors of recurrence. The recurrence data will
be available to other researchers through existing mechanisms, so resource sharing will be enabled from the
outset. Furthermore, as the infrastructure solidifies and the methods are optimized, the recurrence registration
protocols will be transportable to cancer registries with similar infrastructure and legal authority .

Public health relevance
Project Narrative Non-metastatic cancer patients and their physicians need information about the short-term and long-term risks of recurrence, and how these risks vary with age, gender, race-ethnicity, other demographic characteristics, tumor characteristics, and received treatment. We aim to make the Georgia Cancer Registry the world’s first cancer registry to record recurrence information for four cancers that account for 4 in 9 incident cancers, and to use this information to describe recurrence patterns. Given its large and diverse population and high quality cancer registry, Georgia is the ideal setting to implement the world’s first registry of cancer recurrences.